Developmental switches regulating tissue cyst formation

? DESCRIPTION (provided by applicant): Toxoplasma gondii infections continue to be a public health hazard for millions of individuals that contact this pathogen annually. More than 50 million individuals in the US are chronically infected with Toxoplasma gondii and thousands of healthy individuals develop eye disease due to this infection that can lead to permanent vision loss. The Centers for Disease Control and Prevention considers Toxoplasma one of the five most important neglected parasitic infections. Individuals can be reasonably treated (despite significant side effects) if clinical toxoplasmosis is presented, however, there is a lack of drugs to treat or prevent the tissue cyst that is responsible for long-term infections. This therapy failre leaves at-risk individuals who become infected vulnerable to disease relapse throughout their lifetimes. Understanding the developmental mechanisms responsible for tissue cyst formation are needed to develop therapies to combat life-long disease. The Toxoplasma biology that underlies chronic disease is a reversible transformation of the asexual replicating tachyzoite into the latent bradyzoite stage. This critical developmental transition is accompanied by significant changes in gene expression controlled by poorly defined transcriptional mechanisms. Recent experiments of our group have identified key cell cycle regulated and stress-induced Toxoplasma ApiAP2 factors that prevent or activate bradyzoite gene expression. We hypothesize these discoveries reveal a transcriptional network that directs the competing needs of tachyzoite growth against development of the dormant tissue cyst required for parasite transmission. To understand how this transcriptional network operates, we propose two specific aims: In Aim 1, the experimental focus will be tachyzoite cell cycle repressors (AP2IV-4, AP2IX-4, AP2X-11, and AP2XI-1) whose mechanisms we will define at the molecular level and characterize in cell culture and animal models of parasite development. In Aim 2, we will determine how the stress-induced AP2IX-9 repressor and AP2IV-3 activator compete to control bradyzoite gene expression and explore how these mechanisms influence parasite development in animals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Toxoplasma gondii infections continue to be a public health hazard for millions of individuals that contact this pathogen annually. Chronic infections with thi pathogen are prevalent in the US populations and elsewhere in the world (1 in 2 chance if infection by age 50), yet Toxoplasma remains a neglected protozoan pathogen in public health investments. Life-long Toxoplasma infections are due to the development of the tissue cyst, which is effectively invisible to the immune system and currently untreatable. Studies of the mechanisms that control bradyzoite-cyst formation are critically needed if new approaches to combat toxoplasmosis are to be developed.